Transposable Element (TE) RNA regulation via small RNA pathways in aging cells and neurodegeneration.

Project Summary/Abstract
Transposable elements (TEs) are prolific genetic parasites infiltrating >45% of the human genome and are
major proportions of all animal genomes. TE activation during aging and disease affects the transcriptomes of
neurons and alter animal activity. This hypothesis is attractive because all animal genomes harbor a major
reservoir of active TEs that are latent when animals are young but are activated during aging and disease. Our
lab studies how the natural RNA interference (RNAi) system recognizes and silences TE transcripts to
preserve genome stability. To fundamentally uncover the regulatory mechanisms between animal genomes
and TEs in neurodegenerative disorders, we are deploying genetics, genomics, biochemical and small RNA
analytical approaches on the RNAi pathway.
This proposal will investigate how TE RNAs activated during aging are regulated by processing into small
RNAs via natural RNAi pathways. This study leverages our lab’s previously established investigations of TE
regulation during Drosophila aging, and we will bring new insight into how human TE RNAs are also processed
into small RNAs during human aging and how these TE small RNA levels are affected in diseased states. The
ultimate goal will be to examine how TE RNA regulation is affected during animal aging and in
neurodegenerative disorders such as Alzheimer’s, Parkinson’s, and Huntington’s diseases.
This project will achieve the following aims in this project: Aim 1: Decipher the chromatin states associated
with elevated TE expression in aging Drosophila and human cells; and test genetic interventions that modulate
RNAi regulation of TEs in human cells and Drosophila with knockdowns and mutations of genes linked to
neurodegeneration in order to measure the feedback to disease phenotype suppression and preserving
chromatin states. Aim 2: Determine the range of human brain TE small RNAs during development and aging;
and determine the range of human brain TE small RNAs being affected in neurodegenerative diseases. Since
the field still lacks a complete understanding of TE RNA processing events during animal aging, our multi-
prong genetic and genomics approach in the Drosophila model system will complement the translational
objectives of characterizing the TE RNA regulation process in human cells and brain samples.

Public health relevance
Project Narrative To fundamentally uncover the regulatory mechanisms between animal genomes and TEs in neurodegenerative disorders, we are deploying genetics, genomics, biochemical and small RNA analytical approaches on the RNAi pathway in the Drosophila model system to complement the translational objective of characterizing the TE RNA regulation process in human cells and brain samples. TE activation during aging is an intriguing hypothesis behind neurodegeneration because all animal genomes harbor a major reservoir of active TEs that are latent when animals are young but are activated during aging. This study leverages our lab’s previously established investigations of TE regulation during Drosophila aging, and we will bring new insight into how human TE RNAs are also processed into small RNAs during human aging and how these TE small RNA levels are affected in diseased states.